INTOXICATED SEXUAL ENCOUNTERS: ALCOHOL, SEXUAL SCRIPTS AND CONSENT AMONG YOUNG ADULTS

7. Project Summary
The aims of this 36 month qualitative research project are as follows: a) Identify gendered differences in
the meanings and roles of intoxication within sexual encounters; b) Explore the extent to which different
drinking contexts, and normative cultures that operate within them, influence sexual encounters; c) Examine
the ways in which social structural inequities, such as gendered power relations, influence the meanings and
outcomes of intoxicated sexual encounters; d) Produce practice-based evidence, informed by a systematic
constitutive analysis of qualitative narrative data, that can inform promising innovations for the development of
sexual victimization prevention and education initiatives. This evidence can also provide important information
for the formulation of new guidelines and practices for the operation of nightlife establishments.
Although concern about sexual violence, victimization and harassment has increased, much of the
recent attention has been to address these issues within the workplace. Hence, much less focus has been
directed towards addressing these issues in drinking settings. This is in spite of the extensive research that has
identified the role of alcohol as a major contributory factor in sexually violent and aggressive behaviors.
However, while epidemiological and survey research on intoxication and sexual encounters has been
important, limitations with this research need to be addressed. Furthermore, while social science research on
contemporary sexual encounters and sexual consent has increased, especially among young adults, much
less research has examined the social dimensions of intoxication in the context of sexual encounters.
Consequently, we will adopt an alternative theoretical framework combining insights from existing social
science research to emphasize both the socio-contextual and structural aspects of intoxicated sexual
encounters. Additionally, this proposed project considers these issues among diverse groups of young adults,
not only those enrolled in college, who have been the primary focus of existing research on sexual encounters.
By combining theories from several fields and research traditions, we can expand the current state of
understanding of the meanings, processes, and implications of intoxicated sexual encounters for young adults.
Our proposed project will examine the following three research questions:
1. How do young adults understand and conceptualize the role of intoxication in shaping sexual
encounters, consent and victimization?
2. To what extent do different intoxication settings, such as bars, clubs and parties, influence the
processes of sexual encounters, consent, and victimization?
3. How do socio-structural factors (cultural scripts of sexuality and gendered intoxication, gendered
power relations, gender inequities) influence the processes involved in intoxicated sexual encounters?
In order to examine these issues, we will conduct in-depth interviews with 200 young adults using a
qualitative interview schedule, which includes a closed-ended survey, detailed open-ended questions, and
innovative qualitative elicitation techniques. We will disseminate findings through a project website
(criticalpublichealth.org) that includes an accessible presentation of study findings and a social media forum to
solicit feedback from study participants and people concerned about alcohol-related problems associated with
intoxicated sexual encounters.

Public health relevance
8. Project Narrative Alcohol researchers have long sought to disentangle the precise relationship between intoxication and sexual encounters. Examining the relationships between intoxication and sexual health have been important for public health researchers in developing effective prevention and intervention programs to counter a number of serious alcohol-related problems. In order to assist the development of more effective intervention programs, but also importantly further our understanding of the relational processes that are involved within these intoxicated sexual encounters, the aim of this qualitative research proposal is to identify and analyze the key elements operating by conducting in- depth qualitative interviews with 200 young adults (18-25).